Vulnerable and Resilient Cells in Retinal Degeneration

PROJECT SUMMARY
Inherited retinal degeneration (IRD) is a group of genetic diseases featuring progressive loss of
photoreceptor neurons in the retina and eventual blindness. Affected photoreceptors largely die through
apoptosis that was once thought to be irreversible. However, recent studies in different systems have reported
a phenomenon called “anastasis”, in which some cells that received an apoptotic signal become resilient and
return to a healthy state. The presence of resilient photoreceptor cells after light damage was suggested by
several studies, but there is no clear data on photoreceptors in retinal degeneration or knowledge of underlying
cellular/molecular mechanisms. This application aims to close this knowledge gap by testing our hypothesis that
each photoreceptor cell has an intrinsic capacity to “self-repair” or recover from apoptosis, and that therapeutic
treatments enhancing this capacity will maintain photoreceptors in IRDs.
To test our hypothesis, we will use mouse models to identify resilient vs. vulnerable rod/cone cells during
retinal degeneration. We have established an in vivo genetic tool, the living-color reporter mouse line, named
CaspBiosensors. In this model, we take advantage of a well-known apoptotic marker, activated Caspases 3/7
(Casp) to label cells that undergo apoptosis (present) with red fluorescence and cells that have survived
apoptosis (past) with green fluorescence. Our preliminary results demonstrate that we can detect present/past
Casp+ photoreceptors in a relevant model by both imaging in live animals and histological sections. In this grant,
we propose experiments to confirm and expand these findings at the cellular and molecular levels. Specific Aim
1 will determine the survival outcome of vulnerable (red) and resilient cells (green) under environmental (light
damage) and genetic (three IRD models) insults, using chronic in vivo imaging-based analyses complemented
by histological examination at end-points. Specific Aim 2 will identify molecular signatures of cellular resiliency
using single-cell RNA sequencing. We will validate selected candidate genes using loss-of-function and gain-of-
function manipulations. We will also investigate the capacity/mechanisms of gene therapy and a proven
neuroprotection reagent in preventing photoreceptors degeneration in IRD models.
The outcome of this research is expected to significantly impact our understanding of apoptotic
photoreceptor degeneration in IRDs and the development of more effective therapeutic approaches. Improving
long-term efficacy of gene therapy is essential as photoreceptors have continued to degenerate even in the few
successful ocular gene therapy clinical trials. Our study will inform potential improvements by adding
neuroprotection strategies to prolong the life of targeted photoreceptors.

Public health relevance
PROJECT NARRATIVE This research aims to understand programmed cell death/survival in mouse models of retinal degeneration and to identify cellular pathways that promote cell survival. Living-color reporters named CaspBiosensors will be used to identify cells that will eventually die (vulnerable) and other cells that are reverse their death signal (resilient). The cellular and molecular features of these vulnerable/resilient cells will be investigated to inform the development of neuroprotection therapies.